Genotype-phenotype Correlations In Movement And Neuromus

The Clinical Neurogenetics Unit research program is focused on identification and characterization of genes and genetic mechanisms involved in hereditary a) movement disorders, b) neuromuscular disorders, and c) prion diseases. Major findings: Twenty-two causative mutations in the desmin gene have now been identified and described, and adverse effects of each mutation tested in a cell culture expression system. Several clinically and pathologically distinct variants of desminopathy have been outlined. There is a correlation between the clinical syndromes and the position and type of the causative mutation in the desmin gene. Two disorders previously considered to be independent, type 5 of distal spinal muscular atrophy (dSMA-V) and type 2D of Charcot-Marie-Tooth disease (CMT2D) are associated with mutations in the same GARS gene, suggesting that these disorders are allelic, or perhaps represent the same disease, since phenotypic differences are not significant. This conclusion requires changes in the existing classification of peripheral neuropathies. Genetic susceptibility to kuru and new variant Creutzfeldt-Jakob disease is tightly linked to a M/V polymorphism in the PRNP gene, providing a model for predictions of the expected length and size of the developing epidemic of variant CJD associated with mad cow disease. Tremor-dystonia type of essential tremor in two large American families is shown to be linked to a 7 cM locus on chromosome 6p and a 21 cM region on chromosome 1p. Patients with definite Viliuisk encephalomyelitis show evidence for intrathecal IgG synthesis correlating with the clinical manifestations of the disease. The detection of oligoclonal IgG banding will be used as a valuable diagnostic assay.